What is going on in the fish's brain? Characterization and Modeling of Neural Dynamics (CNS and ANS and ICNS)

Project 2
It is the behavioral algorithms that dictate the questions and framework for any model of neural implementation. Thus, to
discover how behavioral algorithms are implemented and to generate a realistic brain-body circuit model for larval
zebrafish, we need, in addition to knowledge about the anatomical structure of the circuits, detailed information about
neural activity patterns during behavior. Further, behavioral algorithms must be implemented in the context of the
embodied animal, which is subject to physiological demands, fluctuations and constraints. In order to accommodate both
of these requirements, we will estimate and incorporate these physiological state variables into our modeling framework.
In order to obtain the necessary datasets, we propose to add detailed measurements of heart and gills, as well as body wide
recordings from the autonomic nervous system (ANS) and the intrinsic cardiac nervous system (ICNS) to our
experimental repertoire. Such recordings will be combined with established brain wide imaging technologies, where we
will focus on critical regions, such as the hypothalamus and various other areas that were already identified to play an
important role in the modulation of behaviors and internal states. To facilitate the quantification and control of
state-dependent variability, we have also designed a set of behavioral assays where environmental context is modulated to
induce specific changes in the animal's internal and autonomic state.
The comprehensive data sets collected in these experiments then allow for the generation of a family of realistic circuit
models that could, in principle, implement the behavioral algorithms and that can reproduce and emulate the recorded
neural and cardiac activity patterns. These realistic models allow for the generation of specific predictions and hypotheses
about many of the unconstrained parameters in the underlying circuits. Such parameters include specific connectivity
patterns, the synaptic weights, the excitability of membranes and many more. In order to constrain this large variety of
variables one needs to apply a variety of independent approaches. To that end we will take advantage of the extensive
experimental toolset already developed in the context of the current U19 grant, which includes the use of optogenetics
based circuit interrogation, targeted electrophysiology and sparse connectomics tracing in overlaid EM volumes. Many of
these experimental approaches require tethered behavioral preparations which are already established in our laboratories.
Such preparations provide the ideal setting for brain wide imaging and targeted perturbation, and they will therefore
facilitate the generation of a further refined set of validated circuit models for our various behavioral assays.
To summarize, our goal is to first validate and constrain a set of realistic circuit models that we have already generated in
the context of the current U19, to integrate these validated models with a novel framework we will generate for the
animal's autonomic state, and ultimately to combine all of them into a composite realistic multiscale circuit model of the
zebrafish brain and body. This multiscale circuit model will describe how all sensory stimuli, from the outside world as
well as from inside the body, are encoded and transformed into distributed neural activity that generates the motor
sequences that constitute the final output of the system.

Public health relevance
The research plan we propose aims at a comprehensive multi-level understanding of how the brain and the body interact to respond adaptively to a potentially harsh and unforgiving environment. Among the many internal factors that are under constant homeostatic regulation, we focus on the bi-directional dialogue between the brain and the heart, since the cardiovascular system and its role in regulating oxygen delivery is one of the most critical and universal control systems within the animal kingdom. A central aspect of our approach is the generation of a complete brain and body connectome of the larval zebrafish, a map which will be the first ever generated in a vertebrate, and which will be critical in both testing the validity of many extant models, and perhaps discovering new pathways within the interconnected neural circuits that serve the changing needs of the body during behavior.